Understanding IgE Biology

Project Summary
IgE-mediated allergic disease is a growing problem. The pathogenesis of allergic disease requires that
immunoglobulin (Ig) E (IgE) molecules be produced against what are otherwise usually innocuous substances.
Upon activation in the setting of cytokines such as IL-4 or IL-13, B cells can undergo IgH CSR to IgE. IgE
secreted from B lineage cells can, in the presence of cognate antigen, activate mast cells and basophils to
release potent inflammatory mediators. While IgE responses can lead to protective immunity as a part of a
specialized responses to multicellular pathogens or other noxious threats, they also underlie allergic disease.
Allergic disease can be manifest by localized inflammation, or by multiorgan involvement, including deadly
systemic anaphylactic reactions via IgE-sensitized mast cell degranulation. Thus, the production and
dissemination of IgE play a significant role in dictating the strength and extent of tissue mast cell sensitization.
It is therefore critical to understand not only how B cell IgE production and maturation is controlled, but also the
principles underlying distribution of IgE from point of origin to distal sites throughout the body. The overall
objective of this application is to understand biological aspects of IgE production and dissemination and to gain
insights into how this is influenced in allergic disease. Emerging literature and preliminary data from the
applicant suggest a general hypothesis that biological constraints cooperate to restrict IgE dissemination under
homeostatic conditions, and that accumulation of bone marrow IgE long-lived plasma cells is an aberrancy
underlying systemic manifestations of allergic disease. This hypothesis will be tested by pursuing three specific
aims, which are: 1) to determine the mechanisms of IgE expression dynamics on IgE B cells; 2) to elucidate
mechanisms underlying IgE distribution from point of origin to effector sites; and 3) to characterize IgE plasma
cells in allergic patients. Under the first aim, IgE mRNA splicing and IgE surface density will be genetically
perturbed to examine the hypothesis that splice bias-mediated dilute IgE BCR density limits independent IgE
GC B cell evolution potential. Under the second aim, models of anatomic location-specific allergic challenge
will be deployed to examine the degree to which IgE distribution is locally biased, and the role of naïve
bystander B cells in this process. Under the third aim, bone marrow aspirations from healthy and allergic
individuals will be obtained for IgH isotype-resolved deep sequencing as well as single cell transcriptomics to
elucidate the cellular sources and biological properties of IgE in patients with long-standing severe allergies.
This contribution is significant because it is expected to elucidate a more complete picture of how IgE
responses are regulated. Ultimately, such knowledge has the potential to inform the development of new
strategies that will help to reduce the growing problem of allergic disease.

Public health relevance
Project Narrative The proposed research is relevant to public health because a better understanding of how IgE is produced and regulated is ultimately expected to increase understanding of health issues related to allergic disease, in which IgE plays a key role. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to developing fundamental knowledge that will help to reduce the burdens of human disability.